Imaging Cytometer

PROJECT SUMMARY/ABSTRACT
The University of Iowa Flow Cytometry Facility was established in 1979 and currently serves 128 principal
investigators spanning 31 departments across four colleges. This group continuously receives NIH support for
their work on diverse biomedical research projects that advance our understanding of biological processes that
are essential for human health and identify novel methods to detect and treat a wide variety of diseases.
Recent advances in flow cytometry, microscopy, and single-cell sequencing have increasingly enabled
researchers to identify specific cell populations. Consequently, our investigators require cutting-edge
instrumentation that can accommodate a wide range of experimental conditions to address new research
questions that arise due to these expanding technologies. Currently, our Facility operates six heavily used
benchtop flow cytometers. However, the Facility lacks an imaging cytometer, which harnesses the high
throughput, statistically robust data acquisition of a flow cytometer with the imaging and morphological
capabilities of microscopy. In the absence of this, investigators must run samples on a flow cytometer to
generate quantitative data and use the rest of their sample, or a duplicate of their sample, to generate
qualitative images on a microscope. This workflow is incompatible with rare cell populations, limits the rigor
and reproducibility of experiments due to different labeling schemes, and is costly and time consuming. The
nearest publicly accessible imaging cytometer is over 200 miles away. This lack of accessibility to an imaging
cytometer has a significant adverse impact on the ability of our investigators to obtain detailed images and
corresponding robust statistical data to assess a wide range of biological questions. Thus, there is an urgent
need to acquire an imaging cytometer in the Flow Cytometry Facility at the University of Iowa so investigators
can expand their capacity to understand cell morphology, identify subcellular localization, assess protein-
protein interactions, and distinguish specific cell staining from background in rare cell populations in a
quantitative manner, which will enable them to advance their research in new directions.
This proposal requests funds for a Cytek Amnis ImageStreamX MkII imaging cytometer to provide NIH-funded
investigators and other researchers at the University of Iowa with access to an instrument that can generate
both qualitative and quantitative data, thus reducing the time needed for data acquisition, sample degradation,
and sample-to-sample variation in the case where different samples are run using flow cytometry vs
microscopy. This will allow for continued support and enhancement of research projects carried out at the
University of Iowa and in the state of Iowa, many of which are part of clinical trials or crucial pre-clinical or
basic science studies, and will ensure the Facility continues to meet its overall goal of providing state-of-the-art
instrumentation that supports biomedical research to improve our understanding of human health and disease.

Public health relevance
Project Narrative University of Iowa researchers use flow cytometry and microscopy to study human diseases or their associated therapies, such as prostate and breast cancer, multiple myeloma, lymphoma, cancer metastasis, autoimmune disease, immunotherapy, neurodegenerative disease, influenza, SARS/COVID infection, cellular effects of PCB pollutants, and stem cell therapies. The cells that hold the key to understanding and treating these diseases are often present in minuscule numbers and cannot be readily examined with both technologies in the same experiment, which necessitates the acquisition of an imaging cytometer to ensure these unique cell populations can be quantitatively and qualitatively examined concurrently. Ensuring University of Iowa investigators are equipped with state-of-the-art instrumentation to perform these studies will enable advances in our understanding of human health and disease and allow us to uncover therapeutic avenues to treat adverse conditions.